Colorado Summer Institute in Biostatistics (CoSIBS)

? DESCRIPTION (provided by applicant): The Summer Institute for Research Education in Biostatistics (SIBS) program has established a highly effective network of SIBS sites. There is essential need and interest in a new SIBS program in the western US in order to broaden the reach of the program. The Colorado Summer Institute for Biostatistics (CoSIBS) will meet the need and extend the reach of the SIBS network. In keeping with the program objectives, CoSIBS will inspire the next generation of biostatisticians and data scientists to pursue advanced study and research careers in the biomedical, behavioral, and quantitative health sciences. We will recruit an enthusiastic and diverse group of advanced undergraduate and early-stage graduate students who are interested in exploring the frontiers of data sciences in the development and application of new methods for using big data to guide the diagnosis, care, and prevention of disease. The proposal is structured to provide innovative educational programs using the established research in biomedical data sciences with NHLBI-related research programs that cut across departments at University of Colorado Denver and affiliated institutions. The proposal draws together a range of faculty including faculty from the Department of Biostatistics and Informatics, the Department of Mathematical and Statistical Sciences, and faculty from other departments with research interests in bioinformatics and other aspects of data sciences. CoSIBS will be a 6-week resident summer institute for approximately 20 advanced undergraduate students or recent graduates. The institute will consist of approximately 4 hours per day of class and laboratory instruction. The didactic portion will be at a standard that would be typical of a one-year course in basic statistics as often required in undergraduate curricula. In addition, students will have mentored projects that are tied to ongoing research groups at UCD and affiliated institutions. Projects will be co-mentored by a data scientist specialist in biostatistics, statistical genetics, or bioinformatics, and a companio biomedical investigator from a leading NHLBI-related research group at UCD. The projects will reinforce course content in study design, data analysis, software applications, and the preparation of results for publication or presentation to biomedical researchers.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Colorado Summer Institute in Biostatistics (CoSIBS) will respond to the "Call to Action" to train the next generation of biostatisticians. The institute wil fill an important need in the western US. The program will be led by experienced senior teaching faculty with a strong commitment to biostatistics education. CoSIBS will inspire the next generation of biostatistician scientists to meet the long-term needs for new methods, study design, data analysis, and scientific leadership to assure the continued success of biomedical research as a cornerstone of public health practice and patient care.